Core A: Administrative Core

Administrative Core (Core A) ? Project Summary The Administrative Core will ensure that ADCC scientific and programmatic goals are achieved by providing visionary oversight and effective governance to all Center activities, and scientific direction to the Center as a whole. The Core will be directed by an Executive Committee, composed of the PI, Associate Directors, Core and Service Leaders, and the Program Manager. The Executive Committee is guided by an Internal Advisory Committee (IAC), composed of institutional leaders. The IAC members meet regularly to facilitate the growth of AD research at Wake Forest. The Core will be also guided by an External Advisory Committee (EAC), chosen in consultation with the NIA and composed of members of other ADCs and scientific leaders. We also receive input about ADCC interactions with our community through our community advisory board. The Administrative Core's Committee for Resource Utilization and Research EXpansion (CRUX) will oversee a coordinated series of activities to ensure the expansion of AD-related research and leveraging of ADCC resources by Wake investigators. These activities include: 1) a pilot grant program with themes of strategic importance to the ADCC; 2) quarterly mini-retreats with other Wake Forest Centers to foster collaborative research; 3) monthly presentations that provide information about Center resources to Departments and Centers; 4) partnership with the Clinical Translational Science Institute (CTSI) which serves as a hub for Wake Forest investigators; and 5) partnership with Wake Forest Innovations', a division that connects ADCC investigators with industry partners and clinical research organizations (CROs) that can facilitate their research programs as needed. Through these coordinated activities we will ensure that ADCC resources contribute to high-impact research and that new clinical and basic scientists are brought into the field. CRUX will also facilitate the rapid and successful integration of our new ADCC into the existing ADC network to expand inter-ADC interactions and to rapidly provide our extensive data and biospecimen resources to NACC, NCRAD, and other ADCs. The Administrative Core will accomplish the following Specific Aims: 1) to provide leadership and oversight of the Wake Forest ADCC to ensure its coherence, interdisciplinary nature, and translational focus, and to provide effective stewardship of scientific and programmatic goals; 2) to develop and oversee strategic activities that expand AD research and education at Wake Forest and that promote impactful utilization of ADCC resources locally and nationally; 3) to support novel pilot projects from junior investigators and new AD researchers; 4) to fully integrate the Wake Forest ADCC into the national ADC network, NACC, and NCRAD; and 5) to ensure that all activities undertaken in association with the ADCC comply with the most rigorous standards set by university, state, and federal regulations regarding human subjects, animal welfare, financial policy, and scientific and ethical integrity.